Multidisciplinary Training Program in Basic Diabetes Research

ABSTRACT
Despite impressive advances in diabetes care over the past three decades, the burden of diabetes and
its complications continues to grow, underscoring the need to train the next generation of diabetes
researchers to develop new avenues for prevention, treatment, and cure of diabetes. The primary goal
of this grant is to train PhD basic scientists for careers in diabetes research. The training includes
formalized multidisciplinary learning, along with mentorship and laboratory research experiences
required to develop a deep understanding of the molecular aspects of diabetes. This training program
is embedded within the rich intellectual environment of the University of Michigan, which includes a
highly collegial and interdisciplinary diabetes research community, and excellent core resources for
biomedical research. The training program builds on the remarkable expertise of preceptors, which fall
into seven major interest groups – islet biology and autoimmune diabetes, hypothalamic regulation of
metabolism, mechanisms of insulin resistance and metabolic control in liver, adipose tissues and
muscle, diabetes complications, and therapeutics. The program includes training in individual research
laboratories and is supplemented by a core curriculum - with lectures on molecular pathogenesis of
diabetes, responsible conduct of research, and a course in either bioinformatics, entrepreneurship,
and/or grant writing. In addition, the trainees attend a variety of interdisciplinary seminars, grant writing
workshops, career strategy workshops, and meet with visiting speakers. The director mentors the
trainees in individual and small group sessions. This training is designed to provide the necessary tools
for transition to independence. This program includes 42 successful mentors in a highly collaborative
environment, all with stable extramural funding. The mentors are diverse in their area of specialty, with
appointments in Schools of Kinesiology, Literature Sciences & Arts, Engineering, and many
departments and divisions within the School of Medicine. This program will provide a significant
complement for the missions of our NIH-funded Diabetes Research Center, Nutrition and Obesity
Research Center, and Caswell Diabetes Institute. This training program will be administered through
the Division of Metabolism Endocrinology & Diabetes and will be overseen by an executive committee
comprising the Principal Investigator and other senior investigators with strong mentoring track records.

Public health relevance
PROJECT NARRATIVE Our program provides basic science trainees with the tools they need to develop a deep understanding of the molecular aspects of diabetes through strong laboratory-based research experiences, excellent mentorship, and an academic environment with a focus on multidisciplinary and comprehensive diabetes research. Training is a combination of immersion in specific research projects under the direction of experienced and accomplished senior researchers, formal education, and participation in a variety of other research-related educational activities. This training program fills a critical need to increase the number of future leaders in diabetes research.